Molecular investigation of siderophore secretion and drug efflux by Mycobacterium tuberculosis

Project Summary - Molecular investigation of siderophore secretion and drug efflux by Mycobacterium
tuberculosis
Iron is essential for growth of Mycobacterium tuberculosis, but most iron in the human body is tightly bound to
proteins. The presence of many iron-sequestering proteins and other iron-restricting factors in the lung
granulomas of tuberculosis patients establishes an iron-deprived environment for M. tuberculosis in the human
host. To prevent iron starvation, M. tuberculosis secretes siderophores, small molecules with high iron-binding
affinities called mycobactins and carboxy-mycobactins. Our extensive preliminary data revealed that
siderophore secretion is mediated in M. tuberculosis by a multiprotein complex composed of the inner
membrane proteins MmpL4 or MmpL5 and other proteins, whose molecular organization is strikingly different
from analogous systems in other bacteria. Overproduction of this secretion system during tuberculosis
chemotherapy is also the main resistance mechanism against bedaquiline, a key drug for treatment of
infections with multi-drug resistant M. tuberculosis. Intriguingly, mutational analysis revealed that the
mycobactin binding pocket of MmpL4 and MmpL5 is also essential for bedaquiline efflux. The proposed
research will shed light on this unique secretion system and reveal the molecular mechanisms of siderophore
secretion and drug efflux in M. tuberculosis.

Public health relevance
Project Narrative - Molecular investigation of siderophore secretion and drug efflux by Mycobacterium tuberculosis Iron is essential for growth of Mycobacterium tuberculosis, but most iron in the human body is tightly bound to proteins. To prevent iron starvation, M. tuberculosis secretes siderophores, small molecules with high iron- binding affinities, by an elaborate multiprotein complex strikingly different from analogous machineries in other bacteria. The proposed research will reveal the molecular mechanism of this unique secretion system, which is also a major drug efflux system and the main resistance mechanism of M. tuberculosis against bedaquiline, a key drug used for treating multidrug-resistant tuberculosis.